Pain, Negative Affect, and Cognitive Dysfunction at the Intersection of HIV and AUD Risk

Alcohol use disorder (AUD) is characterized by neurological deficits, negative affective/emotional states, and a
profound escalation of drinking despite these harmful consequences. The cognitive and affective behavioral
deficits associated with alcohol use are attributed to functional and persistent changes in specific brain regions
including the prefrontal cortex (PFC). Despite its short-term analgesic properties, alcohol also damages the
peripheral nervous system over time to produce a characteristic neuropathy, and the resulting hyperalgesia
(increased pain sensitivity) is hypothesized to potentiate negative affect (e.g., anxiety and depression symptoms)
and negative reinforcement processes to increase motivation for continued alcohol use. Alcohol use also
represents a major exacerbating factor for human immunodeficiency virus (HIV) disease. Even in the postantiretroviral
therapy (ART) era, neurocognitive deficits remain prevalent in persons with HIV (PWH), and HIVassociated
neurocognitive disorder (HAND) and co-occurring AUD can exacerbate these deficits. PWH also
frequently suffer from neuropathic pain and other pain-related symptoms that disrupt physical and emotional
function, interfere with ART adherence, and increase the chance of virologic failure. Pain symptoms in PWH are
associated with specific changes in the brain and correspondingly associate with numerous psychosocial factors
in this population, including anxiety and depression. While cognitive deficits and pain are closely linked in PWH,
few studies have examined the biobehavioral factors that drive these interactions or how alcohol and HIV
exacerbate these conditions. The PFC represents and executes the highest forms of goal-directed behavior, and
its function is compromised in motivational disorders such as AUD. As a potential neurobiological locus at the
intersection of pain and cognitive impairment in PWH, preclinical and clinical studies have implicated a functional
potentiation of the anterior cingulate cortex (ACC) in association with alcohol drinking, cognitive dysfunction, and
chronic pain. From a mechanistic perspective, alterations in neurotrophic support and excitability of vulnerable
cognition- and pain-related brain areas such as the ACC may represent a unifying mechanism contributing to
these pathologies. Our overarching hypothesis is that alcohol and HIV/ART exposure additively increase pain,
negative affect, and cognitive deficits over time in PWH in association with decreased neurotrophic signaling and
hyperexcitability within the ACC. We will examine these factors using a bidirectional translational experimental
design incorporating humans and nonhuman primates. Biobehavioral interventions aimed at reducing alcohol
use and enhancing neurotrophic adaptations in vulnerable brain regions represent a critically underexplored area
of HIV research in the public interest that will also be featured in this proposal.

Public health relevance
Our research program will investigate interactions among alcohol use, emotional pain symptoms, and cognitive deficits in the context of HIV. Findings from these studies will provide new knowledge and therapeutic strategies aimed at alleviating HIV- and alcohol use disorder (AUD)-associated neurological and psychiatric conditions.